A platform for scalable spatial single cell genomics

SUMMARY
The function of human tissues is dependent upon complex interactions amongst millions of substituent cells.
Tools that can systematically measure transcriptional and epigenetic states of these cells, while also recording
their spatial positions, hold great promise in understanding both normal tissue function and its dysfunction in
disease conditions. In this proposal, we build upon our recent invention of Slide-tags, a single-cell spatial
genomics technology, to enable facile, spatial profiling of millions of cells across surface areas spanning tens of
centimeters. We will extend Slide-tags to measure not only transcription, but also epigenetic states and genome
variation within individual cells. Further, we will make Slide-tags profiling compatible with fixed and paraffin-
embedded tissues. The innovations from this project will yield a robust, multiomic spatial platform for the routine
profiling of human tissues at the scale of entire organs.

Public health relevance
NARRATIVE During development, cells are arranged into intricately structured organs that carry out the many functions of the human body. To uncover the individual roles of cells in tissue function, and to determine how cells become dysfunctional in disease, we need technologies that can measure cell states within intact tissues. This proposal will develop a technology called Slide-tags that will enable detailed measurements of cells across entire human organs, shedding light on tissue function in both normal and disease conditions.